Morphogen signaling feedback and dynamics in embryonic patterning

PROJECT SUMMARY
Embryos often send instructions to their cells using diffusible signaling molecules called morphogens. In the
classical model, the morphogen diffuses from a localized source to create a concentration gradient. Cells then
‘read’ this gradient by activating fate-determining genes in a concentration-dependent manner. However, recent
observations have complicated this simple model for several well-studied morphogen patterning systems. First,
embryos often employ extensive feedback on signaling, suggesting that developmental patterning requires more
precise control than diffusion alone can offer. Second, cells can respond to signaling dynamics—rather than
morphogen concentration alone—when making decisions. In this proposal, I will investigate how signaling
feedback and dynamics influence developmental patterning by Nodal, a model morphogen that induces
mesendoderm in vertebrate embryos. Nodal signaling is regulated by broadly conserved positive and negative
feedback loops, however the purpose of this feedback remains a matter of debate. In Aim 1, I will test how
positive feedback contributes to Nodal-mediated patterning by characterizing mesendodermal development in
new zebrafish mutants that lack this regulatory feature. In Aim 2, I will leverage a new optogenetic pipeline for
spatiotemporal control of Nodal signaling to test whether Nodal gradient dynamics influence germ layer selection.
This proposal will clarify the mechanistic basis of Nodal gradient formation and interpretation in vertebrate
development. The work completed in this proposal may clarify how Nodal misregulation creates birth defects in
human embryos and may lay the groundwork for new tissue engineering methods that leverage signaling
dynamics to control cell fate selection. From a training perspective, this proposal will greatly increase my
quantitative biology skills and prepare me for a career as an independent investigator focusing on developmental
biology.

Public health relevance
PROJECT NARRATIVE Nodal signaling induces endoderm and mesoderm in early vertebrate embryos. The proposed research will investigate how Nodal signaling feedback and dynamics enable the embryo to generate precise patterns of these cells. This work may provide insight into the etiology of human birth defects and aid in developing reliable tissue engineering methods.